Salpingectomy for Ovarian Cancer Risk Reduction: Improving Utilization and Informed Decision-Making

Often referred to as the “silent killer”, ovarian cancer lacks specific symptoms and effective screening. Patients
are often diagnosed at advanced stage with poor prognosis. Thus, primary prevention is particularly beneficial.
Conventionally, prophylactic removal of the ovaries at the time of hysterectomy was used to prevent ovarian
cancer, but that causes surgical menopause and impairs patients’ cardiovascular, bone, and cognitive health.
New evidence on ovarian carcinogenesis, however, shows that most ovarian cancers originate from the
fallopian tubes rather than from the ovaries. This reveals a better opportunity for ovarian cancer prevention –
prophylactic salpingectomy (removing the fallopian tubes while preserving the ovaries), which can effectively
reduce ovarian cancer risk without the detrimental effects of hormonal deprivation. It also expands the patient
population that can benefit from ovarian cancer prevention to women undergoing sterilization, a setting where
cancer prevention was not considered previously. Yet, salpingectomy uptake varies widely among providers
with largely unknown reasons, and patients are often unaware of ovarian cancer risk reduction associated with
salpingectomy. The overarching objective of this project is to improve quality of care for prophylactic
salpingectomy by identifying provider- and patient-related barriers to utilization and promoting informed
decision-making. Our specific aims are: 1) to identify distinct practice phenotypes in adopting prophylactic
salpingectomy among physicians and compare physician attributes across these phenotypes; 2) to examine
the role of social contagion among physicians in influencing salpingectomy uptake; 3) to ascertain physician
perceived barriers to salpingectomy uptake and shared decision-making; and 4) to evaluate quality of decision-
making regarding prophylactic salpingectomy from patients’ perspective and identify influencing factors. We
will focus on women who are at low to average risk for ovarian cancer where prophylactic salpingectomy (with
ovarian conservation) confers the most benefit. We will draw on unique data available in large healthcare
databases, including the Premier Healthcare Database, State Inpatient Database/State Ambulatory Surgery
and Services Database, and Blue Cross Blue Shield Axis database, supplemented by primary data collection
directly from physicians and patients through focus groups, interviews, and surveys. This project is innovative
because it studies an adjunctive procedure (among women who are already undergoing surgery) as a unique
opportunity for cancer prevention with little added patient burden, employs a novel latent class growth analysis
to identify distinct phenotypes of physicians in their trajectory (level and slope) of adopting prophylactic
salpingectomy, and applies the nascent social network analytics to study connections among physicians and
how it affects salpingectomy uptake via peer influence (a previously untapped mechanism for interventions).
With over 1.2 million women undergoing hysterectomy and sterilization in the U.S. each year, findings from this
study will enhance our ability to capitalize on this prime opportunity for ovarian cancer prevention.

Public health relevance
Strategies to safely and effectively prevent ovarian cancer can have important public health impact since ovarian cancer causes more deaths than any other diseases of the female reproductive system. New scientific evidence shows that most ovarian cancers originate from the fallopian tubes rather than from the ovaries, and therefore removing fallopian tubes can effectively reduce ovarian cancer risk while allowing patients to preserve the ovaries that are beneficial for cardiovascular, bone, and cognitive health. The proposed project seeks to identify physician- and patient-related factors that influence the adoption of this new approach to ovarian cancer prevention and inform ways to improve utilization and informed decision-making.